Cancer Research and Career Enhancement

Cancer Research Career Enhancement: Summary/Abstract
The strong commitment of the HDFCCC to education and mentoring is reflected in Center-specific efforts, as
well as in the integration and coordination between the HDFCCC and other UCSF-wide career enhancement
programs and initiatives. The HDFCCC has leveraged the rich learning environment, resources and
opportunities available within the greater UCSF campus community, to complement HDFCCC activities.